Estimating the population size of persons who inject drugs in New York

Abstract
Racial minorities have disproportionate risk for SARS-CoV-2 diagnoses and adverse outcomes including
death. Burden of disease in Black populations is likely underestimated due to sub-optimal access to, and
usage of, SARS-CoV-2 testing. Serosurveys, which use probability-based methods to select persons for
SARS-CoV-2 testing and an accompanying survey, have potential to improve our understanding of population-
level burden of disease and risk factors for infection. However, early results from U.S.-based serosurveys
indicate sub-optimal participation rates among Black populations, which results in their under-representation in
burden of disease estimates and a limited understanding of risk factors for infection. The current project aims
to identify barriers and motivations for participation in population-based SARS-CoV-2 serosurveys among
diverse Black sub-populations (e.g. by gender, age, and education level). Understanding factors that influence
Black people's decision-making about serosurvey participation and how these factors differ by socio-
demographic characteristics will allow us to provide tailored recommendations for increasing Black populations'
participation in serosurveys and representation in burden of disease estimates. Our interdisciplinary team of
epidemiologists, behavioral scientists, and community health advocates/practitioners will use qualitative and
quantitative methods in the context of serosurveys to understand how influences on decision-making are
related to actual decisions about participation in SARS-CoV-2 antibody testing. Our qualitative interview guide
will be informed by the family of value expectancy theories and will be developed in collaboration with a
community advisory board (CAB), who will also help us to identify community constituents for participation in
qualitative interviews. Key themes from the qualitative interviews, and language used by respondents, will
inform a quantitative survey instrument, which will assess relative strengths of influences on serosurvey
participation and how they differ socio-demographically across Black sub-populations. Our Specific Aims are:
(1) Convene a community advisory board (CAB) comprising leaders from organizations serving Black
communities in Atlanta (e.g., professional, faith-based, health and social services); (2) In the context of a
SARS-CoV-2 serosurvey, conduct 50 semi-structured interviews about barriers and motivations for serosurvey
and vaccine participation with Black persons from 3 diverse neighborhoods, representing a range of socio-
demographic characteristics; (3) Determine the distribution of barriers and motivations for serosurvey
participation across socio-demographic subgroups of 2,000 Black persons using a quantitative survey. We will
provide recommendations for increasing participation of black communities in SARS-CoV-2 serosurveys, which
is critical as SARS-CoV-2 serosurveys are likely to be used for on-going disease surveillance in the U.S. and to
inform both resource allocation and design and monitoring of prevention and control strategies.

Public health relevance
Project narrative SARS-CoV-2 serosurveys are being fielded across the U.S. to measure population-level burden of disease and associated risk factors. However, low response rates to such serosurveys have been observed among racial/ethnic minority communities, who have disproportionate burden of COVID-19 disease and adverse outcomes. In this project, we will assess barriers and motivations for serosurvey participation among black communities, including how they differ by socio-demographic characteristics, in order to recommend strategies for increasing participation and, ultimately, representation in SARS-CoV-2 burden of disease estimates.